The growth of the germline ring canals during Drosophila melanogaster oogenesis

Project Summary
To better diagnose and treat infertility, which affects millions each year, it is essential to understand the molecular
pathways and structures required for normal gamete formation. Intercellular bridges (IBs) are found in developing
sperm and eggs throughout the animal kingdom, including in humans; they provide an essential cytoplasmic
connection between developing gametes or to supporting nurse cells. The IBs, or ring canals (RCs), that connect
germline cells within the developing fruit fly egg chamber have emerged as the premier model system to study
IB structure and stability. RCs are formed following remodeling of the midbody at the end of germline cell
divisions; their formation and subsequent growth are essential for fertility. Many structural and regulatory RC
proteins have been identified, but an integrated model has not been developed. The long-term goal of this work
is to determine the molecular mechanisms that regulate RC formation, stability, and growth during oogenesis.
The PI’s lab has demonstrated that the Misshapen (Msn) kinase localizes to the germline RCs and regulates
their size and stability, but upstream activators and downstream effectors in the germline have not been
identified. Msn can be directly phosphorylated and activated by the Tao kinase in other cell types, but it is not
known whether this occurs in the germline. Altering Msn levels led to changes in the actin cytoskeleton and the
adherens junction (AJ) protein, E-cadherin, but downstream targets of Msn in the germline have not been
identified. Msn contains a citron homology domain, which can bind small GTPases; these molecular switches
can coordinate actin remodeling and AJ turnover. The objective of this work is to test the hypothesis that Msn is
activated by the Tao kinase to coordinate AJ turnover and actin remodeling via activation of small GTPases,
ultimately promoting regulated RC growth. Aim 1 will determine whether Msn contributes to the spatial and
developmental regulation of E-cadherin in the germline. Aim 2 will determine whether one or more small
GTPases (Rho or Rap family) regulate RC size or stability, downstream of Msn. Aim 3 will test the hypothesis
that in the germline, Tao phosphorylates and activates Msn to regulate RC size and stability. Because ring canal
stability and regulated growth require adherens junctions and remodeling of the actin cytoskeleton, the study of
Msn can provide significant insight into these essential germline structures. The proposed aims utilize
undergraduate-appropriate techniques that are established within the PI’s lab. The PI’s strong track record of
mentoring 42 undergraduate student researchers, her expertise in cell and developmental biology, and the power
and accessibility of the fruit fly model system make her well-positioned to complete the proposed aims. Students
will gain valuable training and experience that will increase their interest in STEM fields. The proteins, structures,
and processes being studied are also utilized during normal morphogenesis and can be mis-regulated in disease;
therefore, insight from this work will improve our understanding of normal development and disease in humans.

Public health relevance
Projective Narrative Proper gamete development is essential for fertility, and defects in sperm or egg formation could lead to infertility, which affects millions each year. This work will leverage the power of the genetic model organism, the fruit fly, to study intercellular bridges during egg development. Because intercellular bridges are found in the developing eggs of other animals, including humans, the data generated through this work could improve the diagnosis and treatment of human infertility.